DEVELOPMENT, PRODUCTION, AND DISSEMINATION OF NCI TOBACCO CONTROL MONOGRAPHS

The overall objective of this Task Order is to provide services to support the development, production, and dissemination of up to 2 NCI Tobacco Control Monographs.

The services to be provided by the Contractor involve a range of activities and include administrative support, literature research, technical writing, and intellectual contribution to the production of the Monograph volumes.